The SRBR 2022 Meeting: Rhythms of Life - from Molecules to Policy

PROJECT SUMMARY
We request partial support for the 2022 Society for Research on Biological Rhythms Meeting, to be held at the
Omni Amelia Island Plantation Resort, in Florida, from May 14 to 18, 2022. The conference, which attracts more
than 800 attendees, will focus on several topics that represent key research areas in the field of chronobiology,
including molecular biology, genetics, cell biology, neurobiology, physiology, metabolism, cancer, aging,
infectious disease, immunology, behavior, sleep, mathematical modeling, environmental science and drug
development. The theme of the meeting will be ““Rhythms of Life: from Molecules to Policy.” This theme reflects
the extent to which biological rhythmicity affects all aspects of life in all organisms living in their natural
environment, and the importance of aligning public health and occupational strategies with our understanding of
how biological rhythms influence human and environmental health. The meeting will feature 18 symposia of
invited speakers, 16 slide sessions with short talks, two special sessions, two plenary lectures, and ~400 posters
that combine the best of basic clock research with research that translates this information into the prevention,
diagnosis and treatment of disease. The symposium speakers and session chairs are recognized leaders in their
fields, and were chosen to represent the breadth of the field and realize our goal of bridging basic and applied
circadian clock research. A majority of slide session speakers are trainees (postdocs or graduate students), and
starting in 2022 a limited number of major symposium speakers will be trainees. Large efforts are being made to
recruit scientists from other fields, not usually attending SRBR, as speakers. Special attention has been given to
cultural and geographical diversity as well as gender balance. We aim to attract scientists from diverse
backgrounds through targeted advertisement and, with NIH support, to offer travel fellowships to trainees,
prioritizing those from under-represented groups. Various new and previously successful communication
initiatives will ensure a broader dissemination of knowledge. Training aspects of the meeting are fully developed,
and include a highly subscribed, free, one-day Trainee Professional Development Day, Junior Faculty
Workshops, and a Mentoring Program. Finally, the new 2022 Chronobiology School, directed to graduate
students and postdocs new to the field, will be offered.

Public health relevance
PROJECT NARRATIVE The regulation of physiological and behavioral processes by biological clocks is critical for both physical and mental health. Disruption of the timing of these clocks increases the prevalence of disease and, on the other hand, the diagnosis and treatment of specific ailments is influenced by biological clocks. The 2022 Society for Research on Biological rhythms Meeting will bring together scientists of various fields, different generations of researchers, and various end users and target audiences together with the goals of: (a) training the next generation of diverse researchers in the field of biological clocks and rhythms; (b) sharing the latest findings in this field and (c) sharing key established and new knowledge in the field with the broad public.